Corticostriatal mechanisms of causal inference and temporal credit assignment.

Learning desired actions from experience requires evaluating alternative actions by integrating the
consequences assigned to each action over time. In the real world, actions and outcomes occur in complex
sequences, and a continuous stream of events must be parsed into appropriate pairs of causative action and
outcome before such pairs can be evaluated. However, how the brain solves this problem, known as temporal
credit assignment (TCA) is unknown. The goal of the proposed project is to use an innovative paradigm and
test novel hypotheses regarding the role of heterogeneous dynamics of memory in the prefrontal cortex in TCA.
In our contextual lagged bandit task, monkeys will choose between three options offered in one of two
alternating contexts, but feedback for a choice in one context will be temporally delayed and delivered after
another choice is made in the other context. Learning optimal choices in this task consists of two parts: causal
inference for learning the causal structure or model of the task, and model-based TCA for learning the value of
each choice. Learning from delayed outcome requires memory of a chosen action or eligibility trace (ET).
Although theories postulate that ET exponentially decays over time (i.e. exp-ET), exp-ET cannot resolve TCA
when causative action is separated from the outcome in time and by irrelevant events. We hypothesize the
flexible dynamics of ET might be crucial for causal inference and model-based TCA.
More specifically, we hypothesize that model-based TCA requires dynamically-modulated ET (dynamic-
ET) which is selectively activated at the predicted time of its outcome to obviate receiving credits from
intervening events. For causal inference, we hypothesize that memory of past actions might be re-activated by
hindsight in search of a new causal link (i.e. hypothetical ET, hyp-ET). We also hypothesize that ET might be
strongly sustained until the lagged feedback (i.e. persistent ET, persist-ET) to test the accuracy of new link at
the expense of confounding intervening inputs. We will investigate how flexible dynamics of ETs might be
supported by heterogeneous dynamics of neural activity across different regions of cortico-striatal network.
First, we will assess whether the primate prefrontal cortex (PFC) provides dynamic-ET for model-based
TCA, whereas the striatum provides exp-ET for contiguity-based TCA. Second, we will assess whether
dorsomedial and dorsolateral PFC provide hyp-ET and persist-ET, respectively. We will take a highly
integrative approach and combine multi-scale neural recordings, perturbations and computational modeling to
examine whether and how complex patterns and dynamics of neural activity in the prefrontal cortex constitute
necessary and sufficient conditions to support model-based TCA. The proposed project will transform the
conventional view of memory as storage, recasting memory as an integral part of learning and reasoning with
temporal dynamics being its key structure. Causal inference is central to dysfunction in the individuals with
psychotic symptoms and our work will contribute to understanding underlying prefrontal pathophysiology.

Public health relevance
Understanding causal relationship between one's own actions and external events is human competence critical for building veridical representation of, and selecting desired actions in the complex world. The proposed research takes an integrative approach that combines innovative behavioral paradigm with multi-scale neural recordings, perturbations and computational modeling, to test novel hypotheses regarding the role of heterogeneous dynamics of memory in the primate prefrontal cortex in causal inference. Causal reasoning is often disrupted in the patients with psychiatric disorders and the results from the proposed study will contribute to understanding not only the foundation of human high-order cognition, but also the prefrontal pathophysiology of psychiatric symptoms.